Tailored Behavioral Intervention to Prevent Household and Community Spread of COVID-19 among Latinos

Project Summary/Abstract
The United States currently has the highest COVID-19 infection and related mortality rates in the world. In
California, Latinos account for the highest percent of COVID-19 cases (58.9%) and deaths (47.3%) and are
disproportionately represented in occupations deemed as ‘essential’. Latinos also suffer from higher rates of
poverty and chronic disease which places them at greater risk of COVID-19 infection and related complications.
In collaboration with Family Health Centers of SD (FHCSD) and working with Community Health Workers (aka,
promotores/as), we will implement a tailored intervention to reduce household- and community- spread of
COVID-19 among Latinos. Households of recently diagnosed Latino adults (n=256 households) will be
randomized to one of two groups: 1) Standard-of-Care comparison group, 2) COVID-19 promotor/a Intervention,
who will receive standard of care plus tailored counseling delivered by promotores/as. This project will test the
immediate, mid-term, and long-term efficacy of the promotor/a intervention to prevent household and community
spread of COVID-19. In addition, we will test the efficacy of the proposed intervention on short- and long-term
behavioral, mental, and physical health outcomes. This study aims to reduce the spread of COVID-19 in a
population that has exceptionally high rates of morbidity and mortality due to COVID-19. We will harness our
research team’s extensive experience in developing multi-level interventions working with promotores/as to
promote behavior change among Latinos, and leverage a strong community-academic collaboration that
maximizes community impact and sustainability. This research will lead to the development of sustainable and
scalable community-academic models designed to respond quickly, efficiently, and effectively to both this
existing and future public health threats.

Public health relevance
Project Narrative COVID-19 has disproportionately impacted Latinos and other racial/ethnic minority groups. Effective intervention strategies are needed to stop household- and subsequent community- spread of COVID-19 among Latinos. This study will test the immediate, mid-term and long-term efficacy of a tailored intervention to prevent household and community spread of COVID-19 among Latinos.